Philadelphia Regional Center for Children's Environmental Health

The mission of the Development Core (DC) of the Philadelphia Regional Center for Children's Environmental
Health (PRCCEH) is to cultivate the career development and provide career training for the next generation of
scientists in children's environmental health (CEH) so that they can become independent productive scientists
conducting innovative research in CEH. Dr. Rebecca Simmons will be the Director and Dr. Aimin Chen will
be the Co-Director. We will also identify and encourage early-stage investigators (ESIs) as well as investigators
whose research could be expanded into CEH areas. Special emphasis is placed on developing the skills
necessary for translating research findings in CEH. Women and underrepresented minorities will be strongly
encouraged to participate. Another major function of the DC is to bring together ESIs from all of the institutions
in the PRCCEH to provide a coordinated Children's Environmental Health Scientist Support Program. This
mission is accomplished by: a) maintaining a data-base of all ESIs conducting research in environmental health
science; (b) forming a mentoring committee and developing a formalized career development plan for ESIs; (c)
identifying candidates that can apply for Pilot Project funding, as well as extramural funding; (d) identifying and
supporting under-represented minority ESIs in CEH. These goals will be accomplished by the following specific
aims: Aim 1. Maintain a data-base of all Early-Stage Investigators conducting research in CEH; Aim 2. Establish
the Children's Environmental Health Scientist Support Program for Early-Stage Investigators in the PRCCEH.
The goal of our Children's Environmental Health Scientist Support Program is to provide a transformative
experience so that our ESIs will be equipped with the tools for success as the next generation of CEH scientists.
This will be achieved through a PRCCEH mentoring program, PRCCEH Annual Mentorship Retreat, a Grant
Proposal Review Program, CEH workshops, recruitment and support of CEH under-represented minorities,
continuing education programs, and PRCCEH professional skill training; Aim 3. Build capacity in children's
environmental health sciences research through the Catalyst Pilot Program; Aim 4. Enhance translational
knowledge and capacity of ESI through mentored engagement with regulators, legislators and community
organizations relevant to their research. ESIs will be encouraged to engage in a translational capacity building
program called Community Children's Environmental Health. ESIs will have a translational experience in
regulatory, legislative and community engagement. ESI's will engage either on-site or virtually, learning about
the organization's work and identifying opportunities to translate their CEH work. Aim 5. Establish the
Community-partner participatory support program. We will establish a community-based mentoring program that
will build capacity in community-partner participation. The goals include enhanced community empowerment,
co-learning between community members and scientists, informing community organizing efforts, and linking
research to policy action.